Total Synthesis of Dodecahedrane via Carbon–Carbon Bond Forming Cascades

Project Summary/Abstract
The chemical synthesis of small molecules continues to be a vital area of research. Such efforts can lead
to the development of new and improved methods, provide access to interesting or important scaffolds, and
provide fundamental insight into reactivity and synthetic design that, in turn, can enable future research
endeavors. This proposal is focused on achieving the total synthesis of the complex molecule dodecahedrane
via the development of carbon–carbon bond forming reaction cascades. In Aim 1, a dimeric norbornyl scaffold
will be prepared and utilized in an olefin metathesis isomerization reaction. This endeavor will provide access to
a late-stage intermediate, while enabling the investigation and development of a unique variant of olefin
methathesis for the assembly of molecular complexity. In Aim 2, a symmetrical penta-ene substrate will be
synthesized and used in a unique and ambitious poly-ene cyclization, involving all five alkenes, to access
dodecahedrane in the final synthetic step.

Public health relevance
Project Narrative As pharmaceutical targets become more complex, organic methodologies that form complex carbon skeletons from simple precursors are especially desirable. The proposed research seeks to study classic carbon- –carbon bond forming methodologies and apply them in novel ways toward the synthesis of the complex hydrocarbon dodecahedrane. The chemistry developed in this proposal will provide insight into the synthesis of complex molecules from simple substrates, which constitutes basic research toward the furtherment of human health.